Elucidating Sex Differences in Radiation-induced Cardiotoxicity with Cell Village iPSCs

Project Summary
Radiation-Induced Cardiotoxicity (RIC) remains a concerning health issue, particularly in accidental radiation
exposure scenarios as evident in the Life Span Study of Japanese atomic bomb survivors. However, the complex
interplay of factors contributing to the diverse presentations of RIC remains elusive. This project aims to shed
light on the critical roles of sex hormone “estrogen” and genetic variations in estrogen receptor (ER) signaling in
modulating RIC susceptibility and response. The research takes an innovative approach by combining state-of-
the-art techniques and multidisciplinary expertise. Firstly, a "cell village" strategy will be employed which leverage
pooling human induced pluripotent stem cell (iPSC) derivatives from a diverse cohort of 200 individuals. Pooled
iPSCs will be differentiated into 3D cardiac organoids (iPSC-COs) and treated with varying doses of estrogen
and radiation to simulate different physiological conditions and radiation exposure, respectively. Cutting-edge
single-cell genomics and computational technologies will be employed to scrutinize the resulting transcriptomic
and epigenomic changes in each individual. This will help us identify inter-individual variations and underlying
genetic mutations that contribute to differential molecular responses upon irradiation. Additionally, animal models
will be employed to simulate radiological incidences and corroborate multi-omics data to functional outcomes in
whole organisms. Collectively, these experiments will elucidate the genes responsible for sexual disparity in RIC
and its relation to estrogen signaling which can provide insights into personalized risk prediction and intervention
strategies, addressing a critical knowledge gap in the field of radiation biology and cardiovascular health.

Public health relevance
Project Narrative This research aims to uncover how radiation affects the heart differently in men and women due to sex hormone and how our genetic background play a role in radiation-induced cardiotoxicity (RIC). We will use a special technique called the "cell village" approach with human induced pluripotent stem cells (iPSCs) from 200 individuals to study how genetic variations and radiation exposure impact the transcriptome and epigenome in 3D cardiac organoids. Additionally, we will use mouse model to mimic long-term radiation exposure, aiming to pinpoint the genes responsible for sex-based disparities in RIC and their practical implications for cardiovascular health in irradiated individuals.